Development of a Rat Model to Investigate the Physiology of Telomerase Reverse Transcriptase alternative splicing isoforms

Aging is the greatest risk factor for cardiovascular diseases (CVD) and cancer development. Key primary aging
pathways have been identified including mitochondrial dysfunction, reactive oxygen species damage, genome
instability/telomere dysfunction, and inflammation underpin these two age related diseases. Development of
interventions to slow/attenuate primary aging are of primary importance to healthy life extension. The catalytic
subunit of telomerase, telomerase reverse transcriptase (TERT), has been well recognized for its nuclear role in
telomere elongation. Recently, the importance of TERT splice isoforms for cellular health have been established.
Over the past decade non-canonical mitochondrial functions of TERT have been described to protect cells from
external stressors in a variety of disease pathologies, however no animal model that allows the study of
physiological functions of existing splice variants is available. Understanding the physiological roles of TERT
alternative splicing isoforms is of critical importance to aging, CVD, and cancer development because of their
roles in mitochondrial biology. In direct response to an RFA from the Office of the Director (PAR21-167 -
Development of Animal Models and Related Biological Materials for Research), we propose to generate and
phenotype a transgenic rat model expressing a catalytically inactive splice variant, β-deletion variant (β-del-
TERT) in comparison to a new full-length TERT (FL-TERT) transgenic rat model, and an already generated rat
TERT knockout model. We will use these models to investigate the overarching hypothesis that independent of
telomere lengthening or maintenance (human TERT will not function to elongate rat telomeres), FL-TERT will
maintain mitochondrial functioning to a greater extent compared to β-del-TERT improving function, resilience,
and ultimately slowed primary aging and reduced risk of disease progression. This model will represent a cross-
cutting animal model that will be useful for a variety of research questions in the future well beyond the scope of
these first two aims that we will test. To test our hypothesis the following two aims have been developed. Aim 1
will characterize and compare the newly generated transgenic rats to wildtype rats and existing (Beyer
laboratory) rat TERT knockout animals for mitochondrial function, mitochondrial DNA damage, nuclear DNA
damage, telomere associated DNA damage foci, and markers of cellular senescence in liver, intestine, skeletal
muscle, heart, and the brain. Aim 2 will focus on the vasculature and hematopoietic system and directly test if β-
del-TERT is sufficient to induce mitochondrial dysfunction that impairs endothelial function and promotes myeloid
bias resulting in acceleration of cardiovascular disease progression via reduced endothelial cell dilation,
macrophage polarization, and increased inflammatory stress. Successful completion of proposed work will
provide strong proof of concept that enhancing mitochondrial TERT functions is a potential means to slow primary
aging (reduced mitochondrial dysfunction, oxidative damage, and inflammation) and enhance healthy life
expectation and aging resilience.

Public health relevance
Project Narrative This proposal aims to develop a transgenic rat model expressing β-deletion variant of telomerase reverse transcriptase (β-Del-TERT) to understand the pathological role of this variant in promotion of mitochondrial dysfunction which underpins two major age-related diseases, cardiovascular disease and cancer. This proposal is based on our novel observations that provide compelling evidence for the protective role of TERT in the mitochondria. If carried out successfully, this proposal will validate a new animal model for understanding the physiology of TERT alternative splicing variants and discover molecular or pharmacological strategies to restore protective functions of TERT in aging and disease conditions.